Career Development Core

3. PROJECT SUMMARY – CAREER ENHANCEMENT CORE
The Career Enhancement Core will train the next generation of physician scientists with expertise in the care of
individuals with disorders associated with hyperphenylalaninemia and foster future clinical research efforts in
this group of rare inborn errors of metabolism.